Dynamics of skin sensory specialization during vertebrate organogenesis

PROJECT SUMMARY/ABSTRACT
Organ development and function requires that neurons establish precise cellular interactions with tissue­resident
support cells. For example, touch­sensing somatosensory neurons project peripheral axons to the skin, where
they interact with specialized skin cell types. These specialized skin cells regulate axon development and modu­
late neuronal responses to cutaneous stimuli. Reciprocally, somatosensory neurons influence skin homeostasis.
Although the anatomy of vertebrate skin is well described, little is known about the dynamic process of sensory
specialization of the skin, partly because most studies have focused on mammalian embryos, which has limited
access to live­imaging.
The external development and the availability of unique transgenic tools make zebrafish an ideal model for study­
ing the dynamics of neuron and tissue maturation. This proposal investigates the development of a novel popula­
tion of specialized sensory cells that we identified in the zebrafish epidermis. Preliminary cellular, molecular and
developmental analyses suggest that these zebrafish epidermal cells are the equivalent of mammalian Merkel
cells, specialized mechanosensory cells that detect touch. The experiments proposed here investigate how de­
velopment of these specialized epidermal cells is coordinated with skin and nervous system maturation. In Aim
1, we will use live­imaging and genetic manipulation to characterize how sensory cell addition occurs during skin
growth. Aim 2 investigates the establishment of interactions between axons and epidermal cells and how neurons
promote skin specialization. Finally, in Aim 3, we will use in vivo photoconversion, lineage tracing and molecular
techniques to track the trajectory of skin­resident stem cells as they differentiate into sensory cells. Collectively,
these studies will provide mechanistic insights into organ specialization during development, interactions between
peripheral axons and their target tissues, and potentially point to the origins of touch­sensing disorders.

Public health relevance
PROJECT NARRATIVE Our skin functions as a finely tuned sensory organ that allows us to detect an array of sensory stimuli. The axon endings of somatosensory neurons densely innervate skin where they detect touch, pressure and pain. Specialized skin cells develop during skin organogenesis and influence axon growth, function and repair. To better understand how the skin sensory system develops, this proposal uses zebrafish as an accessible model for studying how specialized sensory cells arise during skin organogenesis, interact with axons and differentiate from stem cell progenitors.